Hematology Central Coordinating Center (HCCC) for the NIDDK Hematology Centers Program

PROJECT SUMMARY
The Hematology Central Coordinating Center (HCCC) serves as a centralized hub for the NIDDK-funded
Cooperative Centers of Excellence in Hematology (CCEH), providing critical support, coordination, and
outreach to advance research in non-malignant hematology. Over the past funding period, the HCCC has
successfully built a robust infrastructure across two institutions—University of Utah and Fred Hutchinson
Cancer Center—streamlining communication, expanding access to resources, and fostering innovation in the
field. With new leadership and a renewed vision, this renewal proposal seeks to significantly broaden the
impact of the CCEH through three key aims. In Aim 1, we will maintain and enhance a cutting-edge
communication platform and administrative framework to coordinate and disseminate CCEH-sponsored
activities. A revamped website now integrates real-time updates, social media dissemination, and user-friendly
features, facilitating seamless access to core resources, training, and collaborative opportunities. Further
innovations, including AI-based protocol generation and troubleshooting forums, will expand engagement and
usability. In Aim 2, we will coordinate and strengthen education and enrichment activities to cultivate the next
generation of non-malignant hematology researchers. HCCC will expand its online seminar series, promote
CCEH resources through major scientific societies, and leverage universal membership to provide targeted
support for trainees and new investigators. Additionally, direct outreach to scientific communities beyond
traditional hematology will foster interdisciplinary collaboration and recruit new talent to the field. In Aim 3, we
will establish an “Opportunity Pool” to develop funding mechanisms that increase accessibility to CCEH
resources. This initiative will provide pilot and feasibility funding, facilitate investigator exchanges between
centers, and support mentorship sabbaticals to enhance technical training. These efforts will ensure that
emerging researchers have the support needed to launch and sustain impactful careers in hematology
research. By advancing these aims, the HCCC will continue to be an essential resource for the non-malignant
hematology community, ensuring that innovative research tools, training, and funding opportunities remain
widely accessible. This proposal builds on a strong foundation while embracing novel strategies to expand
outreach, enhance engagement, and drive progress in the field.

Public health relevance
PROJECT NARRATIVE The purpose of the Hematology Central Coordinating Center (HCCC) is to support, coordinate, and expand the impact of the NIDDK-funded Cooperative Centers of Excellence in Hematology (CCEH). By strengthening communication platforms, broadening educational and enrichment opportunities, and creating new funding mechanisms, the HCCC will ensure greater accessibility to resources, training, and collaborative opportunities for researchers in non-malignant hematology. These efforts will accelerate scientific advancements, support the next generation of investigators, and ultimately improve understanding and treatment of non-malignant blood disorders.